Preclinical Molecular Imaging (PMI)

PROJECT SUMMARY/ABSTRACT (PRECLINICAL MOLECULAR IMAGING)
The Preclinical Molecular Imaging Shared Resource (PMI-SR), previously called Preclinical Imaging and
Computational Analysis, was established in 1986 and has been continuously funded by the Cancer Center
Support Grant (CCSG) since 1988. To optimize growth and development, PMI-SR provides Rogel members
access to state-of-the-art imaging instrumentation including positron emission tomography (PET), 3T and 7T
magnetic resonance scanners, 3D and 4D computed tomography (CT) scanners, and
bioluminescence/fluorescence IVIS systems. Moreover, PMI-SR provides the indispensable scientific expertise
to assist investigators with study design and interpretation of results. PMI-SR supports basic science studies
along with proof of principle studies for eventual integration of imaging into clinical translational studies for further
validation and to serve as companion diagnostics and predictive markers.